Dynamics of cell-matrix mechanical communication during morphogenesis

PROJECT SUMMARY
Tissue and organ development occurs through coordinated cellular processes driven by the
interplay of biochemical, mechanical, and spatial signals. However, the mechanisms by which
such signals are integrated to produce functional structures remain poorly understood. In
particular, we are only beginning to explore the role of extrinsic mechanical signals such as those
originating from the extracellular matrix. The long-term goal of my research is to address this
knowledge gap by investigating how mechanoregulatory signals control cell and tissue behavior
during development. To this end, during this 5-year project, we will focus on dissecting the
mechanisms by which mechanical regulation exerted by the extracellular matrix modulates
cellular mechanisms of remodeling and adhesion to achieve tissue-level deformations. We will
combine powerful optogenetic manipulations together with molecular/genetic perturbations,
biophysical measurements and advanced imaging in in vitro and in vivo. Our approach proposes
an integral understanding of the dynamic and complex nature of cell-ECM mechanical
communication by studying mechano-regulation from multiple angles, ranging from intrinsic ECM
mechanical properties (Gap 1: modulation of active tissue-deformation via ECM viscoelasticity)
to a mechanistic understanding of cell-ECM signaling models remodeling (Gap 2: Cell-ECM
communication mechanisms promoting active ECM remodeling); and adhesion (Gap 3: Interplay
of cell-cell and cell-ECM adhesions driving tissue deformations).This work will provide a more
comprehensive understanding of the dynamic and complex nature of cell-ECM mechanical
communication, which is an essential component to unravel mechanochemical interactions
driving the emergence of cell and tissue organization. Ultimately, the understanding provided by
these studies will have important implications in two main fronts, first, to mechanistically
understand mechanoregulatory signals leading to abnormal events and treat them as potential
mechano-targets; and second, to leverage such signals as a means to engineer functional
tissues in a predictable fashion for use in regenerative medicine.

Public health relevance
Project Narrative Mechanical signals are an essential physical element driving development, and their misregulation leads to abnormal cell function. In this work, we will determine how the complex nature of cell-ECM mechanical communication modulates multiple processes that lead to tissue-level deformations. Identifying how mechanical signals from the ECM regulate cell behavior will contribute to the rational design of systems that fully recapitulate in vivo morphological functionality for a wide range of regenerative medicine needs.